2025 Label-Free Single Molecule Sensing Gordon Research Conference

Project Summary
The ability to precisely detect biomolecules and measure their dynamics is central to our understanding of the
origins of debilitating diseases such as Alzheimer’s and Parkinson’s and is a prerequisite for designing more
effective treatments. However, biomolecules are typically a few nanometers in size, which makes them difficult
to observe with optical methods. One of the primary ways to overcome this challenge is to add labels, such as
fluorescent tags, that make them visible. This has opened the field of single molecule analysis, with the significant
advantages of allowing rare events to be observed, solution heterogeneity to be understood, and molecular
dynamics to be monitored without synchronization of molecular dynamics in an ensemble. At the same time,
chemical tag or genetic modifications can alter a biomolecule’s function and how it interacts with its environment.
Furthermore, fluorescent labels have limited lifetime (photobleaching), time-resolution (finite fluorescence
lifetime) and require additional assay preparation steps that are time-consuming and costly. Given that this area
of research is wide open for exploration, we believe that there is room for knowledge exchange and augmenting
technologies that will evolve into a set of techniques that will become the new standard within academia,
pharmaceutical industry alike. The aim of this inaugural Gordon Research Conference (GRC) is to maximize the
exchange of ideas among these techniques, look at their common issues and solutions, and help with
commercialization efforts so that the world can see their benefits faster. Specifically, we propose to implement
the organization of this inaugural GRC through the following Specific Aims: (Aim 1) To create the first-ever forum
that brings together the top scientists from across the globe in the field of label-free biomolecule sensing
technologies, and (Aim 2) To educate and inspire the next generation of scientists that will move this field further,
paying particular attention to creating opportunities for historically underrepresented students and postdocs.
Through implementation of these Specific Aims, this 2025 GRC will bring together a broadly multidisciplinary
community, including nanotechnology, plasmonics, biophysics, biochemistry, and biology to create new label-
free technologies of single molecule sensors. Rather than focusing on applications, it will be focused on
technology – how do you build new kinds of label-free single molecule sensors, and how do you improve their
performance far beyond the state-of-the-art. We have also taken many steps to create a welcoming, inclusive
community that removes barriers for historically underrepresented groups, women scientists, early career
researchers and minorities. Data on trainee participation and feedback on how their participation helped their
career post-conference will also be collected to ensure the long-term sustainability and impact of this new GRC.

Public health relevance
Project Narrative The inaugural Label-free Single Molecule Sensing GRC will be held at Stonehill College, 8-13 June 2025. Currently dominant single molecule approaches use labelling and tethering of biomolecules, which impacts their biophysical properties significantly. New techniques are emerging that allow label-free studies for understanding the intrinsic behavior of biomolecules. Through this conference, we aim to create a community of researchers with a common vision, from world-leading scientists to graduate students, to develop new techniques that will have a disruptive impact on related health applications.